Assessing effects of manipulation of expression of kinesins in a mouse modelof Alzheimer's disease

PROJECT SUMMARY
The presence of distinct lesions caused by the formation of filamentous deposits of abnormal brain proteins in
neurons is a hallmark of Alzheimer’s Disease (AD). These filamentous deposits contain tau, a prominent
intracellular protein that normally stabilizes microtubules. Fibrillar amyloid beta plaques arising from the
aggregation of amyloid precursor protein (APP) is another hallmark of AD. Several studies have shown that both
tau and APP are key facilitators of fast axonal transport in neurons. Importantly, axonal transport is implicated in
several neuropsychiatric disorders. Though a causal role of axonal transport in AD is not known, several studies
have reported axonal transport deficits both in tau and APP mutant models of AD. Based on our studies on the
effect of manipulation of kinesins that RNAi mediated loss of function resulting in loss of memory whereas
overexpression mediated gain of function resulting in enhanced memory, we here propose to assess the effect
of overexpression of kinesins in APP-NL-G-F knockin mouse model of AD. Specifically we will study the effect
of overexpression in ameliorating plaque formation, microgliosis, synaptic proteins and memory deficit. Based
on our studies demonstrating memory enhancement with Kinesin overexpression, we anticipate to observe
improvements in cytopathology and memory deficit in APP NL-G-F knockin mice. Positive outcomes from these
studies are expected to impact our understanding of pathobiology of AD and discovery of new therapeutic
targets.

Public health relevance
PROJECT NARRATIVE Kinesins are molecular motors that mediate the transport of gene products such as RNAs and proteins, and organelles to mediate synapse function and plasticity. Based on our results that kinesins are transcriptional targets of memory storage and overexpression of specific kinesins results in enhancements in long-term memory, here we propose to assess the effect of kinesin overexpression in ameliorating neuropathological correlates and memory deficits in Alzheimer’s disease (AD). Positive results from these studies are expected to impact development of new therapeutic targets for AD.